The impact of metals and polygenic risk on multiomics, brain aging, and ADRD outcomes

Abstract. The goal of this project is to use genetically diverse mice that better model humans to determine the
sex-specific consequences of exposure to toxic metals/metalloids (Pb, Cd, As, hereafter referred to as
“metals”) on molecular, pathologic, and behavioral changes linked to Alzheimer’s Disease and Related
Dementias (ADRD). While ADRD has a substantial genetic component, emerging research shows exposures,
such as metals, are likely important modifiable risk factors. Exposures to Pb, Cd, and As are associated with
cognitive decline or ADRD in epidemiology studies or ADRD-associated molecular changes, pathology, and
behavior in toxicology studies. Major gaps remain to translate these findings into ADRD prevention and
treatment: (1) Much of the existing toxicology is disproportionately focused on a single inbred mouse strain
(C57BL/6J) rather than advanced models of ADRD genetic susceptibility, which better mimic human variability;
(2) Comprehensive molecular maps of metals effects across brain regions do not exist to help us understand
how metals perturb ADRD biology; (3) Data are limited about whether biomarkers from easily accessible
tissues, like blood, reflect toxicant-associated changes in the brain, an important gap to fill for ADRD
epidemiology. By bringing together a diverse team with expertise in metals toxicology, environmental health
multiomics, genetic mouse models of ADRD, ADRD epidemiology, and data science, we are uniquely poised to
address these gaps. Our long-term goal is to understand how exposure to toxic metals interact with genetics to
drive ADRD. The objective of this proposal is to use AD-BXD mouse strains with widely varying risk for AD to
comprehensively characterize how genetic risk interacts with exposure to Pb, Cd, and As to cause molecular,
behavioral, and pathologic effects. We will test the impacts of lifestage timing of exposure and identify whether
biomarkers measured surrogate tissues reflect ADRD-associated changes in the brain in a sex-specific
manner. We will link our results to human ADRD molecular profiles to assess whether metals-associated
changes are enriched in ADRD patient biological signatures. Our overall hypothesis is that early life metals
exposure interacts with genetic susceptibility to promote ADRD phenotypes and changes in the brain in a sex-
specific manner, which will be reflected by molecular signatures in surrogate tissues. We will test this
hypothesis with three aims: (1) Generate multiomic maps of brain effects of perinatal and adult metals
exposures; (2) Interrogate genetics and metals interactions on ADRD pathology and behavior in later life; (3)
Test for interactions between metals exposure and aging in target and longitudinal surrogate tissues multiomic
profiles. As part of the Precision Environmental Health in AD/ADRD Tri-Consortium, we will generate a robust,
publicly available sample and data resource. We expect this work will have substantial impact on our
understanding of how sex, genetic susceptibility, and timing of exposure influence how metals cause ADRD
effects and whether earlier life signatures in the blood reflect metals-associated changes in the aging brain.

Public health relevance
Narrative. Exposure to metals/metalloids like arsenic, lead, and cadmium may be major risk factors for the development of Alzheimer’s Disease and Related Dementias. The goal of this project is to use advanced mouse models, which better capture genetic risk for Alzheimer’s, to understand how metals/metalloids may cause the disease and provide new strategies for early detection of at risk individuals.